Automated Machine Learning-Based Brain Artery Segmentation, Anatomical Prior Labeling, and Feature Extraction on MR Angiography

Cerebrovascular disease is a major cause of death and disability globally. Time-of-flight magnetic resonance
angiography (TOF-MRA) is a common noninvasive technique to evaluate vascular abnormalities. Accurate
segmentation and feature extraction of cerebral vessels from TOF-MRA data is crucial for diagnosis and
treatment of cerebrovascular diseases. However, manual annotation of vessels is a time-consuming task even
for experts, and an automatic segmentation method can speed-up the task significantly. Although several
machine learning-based post-processing approaches exist, these are limited to vessel segmentation only and
require large manually segmented training datasets. Further, image resolution plays an important role to segment
the vessels as well as extracting features (e.g., diameters, number of branches, tortuosity) accurately.
Aim 1: To develop an automated anatomical prior based machine learning framework for brain artery
segmentation with minimal training MR high resolution data followed by feature extractions on low resolution
MRA from an existing database.
Aim 2: To assess the relationship between targeted vessel features and neuroimaging biomarkers of cerebral
small vessel disease (CSVD).
Aim 3: To assess the relationship between targeted vessel features and cognitive performance in HIV CSVD
cohort.
To achieve this goal, we will implement our recently proposed automated vessel segmentation and feature
extraction pipeline “BayesTract” in combination with a super-resolution approach. We will validate it using in-vivo
MRI scans. We will then examine the vascular features and their associations with CSVD markers and cognitive
performance in an existing dataset (101 HIV+ and 102 HIV- controls with CSVD). We hypothesize that this
approach will provide more accurate and time-efficient measures compared to existing approaches. We also
hypothesize that vascular features and their associations with CSVD markers and cognition will be significantly
different between those with and without CSVD.
This study helps advance the state-of-the-art in brain vessel segmentation and feature extractions from non-
invasive TOF-MRA, which could hasten the translation of vessel related biomarkers into the clinical setting. This
will be essential in evaluating promising interventions and ultimately, lead to ameliorating patient outcome and
quality of life.

Public health relevance
Project Narrative Cerebrovascular disease is one of the major causes of death and long-term disability, affecting 15 million people globally. The goal of this proposal is to develop and validate an automated approach to segment and classify brain arteries and extract vascular features with high fidelity from low-resolution clinical MRA images utilizing a prospective machine learning framework with a small training set for clinical convenience. Advancement in the quantification of vascular features and their associations with markers of cerebral small vessel diseases and cognitive performance will help us to better understand and monitor potential interventions.